Gene Transfer Core, NIDCR-DIR

In FY23, the Gene Transfer Core successfully provided following services:

Pronuclear injection service: 7 CRISPR-based gene editing constructs were injected to generate 34 transgenic lines.

CRISPR-based gene editing service: The average efficiency for generating KO and KI mice for CRISPR-based constructs was 25% and 19%, respectively.

Cryopreservation and IVF services: Sperm from 36 mouse models were cryopreserved for 9 Principal investigators (21 investigators). Sperm from all mouse models were stored in two separate buildings. 16 sperm straws were thawed for 52 IVF sessions.

Genotyping service: 587 tail biopsies were purified and used for genotyping by PCR analysis.